Mechanisms of Neuronal Ensembles in Visual Cortex

Since the pioneering work of Hubel and Wiesel, the mammalian visual cortex has been
used as a model for the rest of the cerebral cortex. In spite of this, little is known about
the detailed operations of its microcircuits. In fact, the cortex is composed of more than a
hundred cell types, and it is likely that each cell type has a particular circuit function.
In a recently ended NEI award we studied the functional properties of the microcircuits
of mouse primary visual cortex and discovered that groups of coactive neurons, termed
“neuronal ensembles”, account for the majority of cortical responses to visual stimuli and
also dominate spontaneous activity. Further, using two-photon optogenetics, we found
that ensembles can be artificially imprinted into the cortex and they can be recalled by
stimulating individual neurons (pattern completion), even days after imprinting.
Confirming their functional role, activating ensembles with holographic optogenetics led
to predictable changes in visual discrimination in a Go/NoGo behavioral task. These
data, confirmed by others, and the widespread alteration of ensembles in mouse models
of disease, suggest that ensembles are microcircuit building blocks of cortical function.
To better understand ensembles we now propose to characterize their basic
phenomenology and cellular identity, understand their biophysical, synaptic circuit
mechanisms and explore the role of inhibitory interneurons. Our preliminary data support
the hypothesis that ensembles are due to increases in excitability and are sculpted by
inhibition. To test this, we will study primary visual cortex of awake behaving mice and
use a novel two-photon holographic microscopy method to image and optically
manipulate neurons in different cortical layers simultaneously. We will also use in vivo
patch clamping of ensemble cells and novel graph theory models to map the circuit,
identify key cells for manipulation and test their role in ensemble activation/suppression.
Our work will provide a systematic description of ensembles in primary visual cortex,
how they work, how they regulate the activity of the cortex and how they can be
manipulated and reconfigured. Neuronal ensembles could constitute functional modules
of cortical function. Understanding the link between ensembles and cortical plasticity
could help design novel therapeutic strategies to treat amblyopia or cortical cerebral
visual impairment by reconfiguring pathological circuits.

Public health relevance
How coordinated neuronal activity arises in the cortex is still poorly understood, yet could be the basis of cortical function. In a past award we discovered that activating neuronal ensembles in mouse visual cortex using holographic optogenetics leads to predictable changes in visual discrimination, and we now propose to explore how these ensembles are formed and how they work. This work could help control cortical activity via activation of trigger cells in ensembles and thus provide novel strategies to ameliorate amblyopia and cortical cerebral visual impairment by reconfiguring abnormal circuits.